MIGRANT AND SEASONAL HEAD START STUDY

The Migrant and Seasonal Head Start (MSHS) Study is a four-year study that will examine the MSHS programs and practices, and the children and families served by the MSHS program. MSHS provides early childhood support for migrant and seasonal farmworkers. The study will examine program practices in multiple domains, including enrollment, recruitment and dual language support. The study will also explore the wellbeing of children and families receiving services. A particular focus of the MSHS Study will be language practice and language assessments utilized across centers.